Signaling and Tumor Microenvironment (STME)

Members of the University of Michigan (U-M) Rogel Cancer Center (Rogel) Signaling and Tumor
Microenvironment (STME) Program share interests that align with five of the nine Rogel cross-cutting research
themes: Tumor Microenvironment & Metabolism; Molecular Determinants; Inflammation, Microbes & Immunity;
Targets & Therapeutics; and Prevention & Early Detection. Members of the STME Program are engaged in
understanding both tumor-intrinsic and microenvironmental effects of altered signaling networks. Investigators
are involved in intra- and inter-programmatic interactions and actively collaborate with Rogel Cancer Center
researchers within the Basic Science, Translational and Clinical Research, and Cancer Control and Population
Sciences Programs. The shared research interests of program members are reflected in the program’s overall
scientific aims: 1) Elucidate the role of cell fate and plasticity during tissue homeostasis and cancer
progression, 2) Define the heterocellular interactions that drive tumor epithelial growth and treatment response,
3) Characterize metabolic and metabolite interactions that impact cancer and growth progression. The Aims
will identify cell autonomous and microenvironmental factors that alter fundamental aspects of tumor initiation,
expansion, invasion and metastasis. Our main goal is to translate the mechanistic findings to improve cancer
prevention, diagnosis, and treatment.